Enhancing Pediatric Treatment Adherence and Health Outcomes

PROJECT SUMMARY
This proposal requests continued support for the “Enhancing Pediatric Treatment Adherence and Health
Outcomes” (T32 HD068223) postdoctoral training program, which trains M.D. and Ph.D. researchers to
assume leadership roles in developing innovative, high impact research on adherence to medical treatment
and chronic illness self-management that will enhance the health outcomes of children with chronic conditions.
Modern medical treatments have improved the health outcomes of large numbers of children and adolescents
with chronic conditions. However, one of the most critical remaining barriers to improving children’s health
outcomes over the course of their lifetime is nonadherence to prescribed medical treatment. As noted by the
World Health Organization (WHO), treatment nonadherence is highly prevalent (rates of ≥ 50% in pediatric
chronic illness populations) and has a significantly negative impact on children’s health and health care costs.
Continued innovative and clinically relevant research is needed to close the gap between the health
outcomes that are potentially achievable with more optimal treatment adherence and those achieved in current
practice. NIH program priorities and requests for applications, scientific consensus conferences, and scholarly
reviews have all identified the importance of research on pediatric adherence to treatment. A critical barrier to
scientific advances in pediatric adherence and chronic illness management research is the shortage of
talented, well-trained researchers who are devoting their careers to developing innovative, high impact
treatment adherence and self-management research with pediatric populations. One of the most promising
ways to address this need and improve child health is to develop innovative interdisciplinary research training
programs to train leaders in the field of treatment adherence and self-management research. This is the focus
of this T32 program. Thus far, we have trained 22 fellows (18 graduates, 4 current trainees) who are
developing promising independent research careers in pediatric adherence and self-management.
Specific training innovations involve the integration of biomedical, behavioral, biostatistics, and health
services/outcomes research and are reflected in a comprehensive training curriculum including experiential
research opportunities. Research innovations include novel methods of adherence assessment and
intervention involving technology designed to enhance the engagement of children and adolescents, improve
the power and duration of intervention effects, and reach diverse populations who cannot easily access
traditional clinic-based approaches. Program innovation is also enhanced by novel research training
opportunities to evaluate the comparative effectiveness of adherence promotion interventions in pediatric
chronic illness management, to integrate objective methods of adherence measurement (e.g., behavioral,
pharmacological, technological) and conduct advanced statistical analyses to evaluate the impact of
adherence promotion interventions on children’s health outcomes.

Public health relevance
NARRATIVE: Graduates of this fellowship program will be national leaders who will have a significant scientific impact on research in pediatric treatment adherence and relevant health outcomes for many years to come. This program will result in effective interventions that will enhance adherence to medical treatment for children and adolescents with a wide range of pediatric conditions. These advances will reduce the extraordinary negative impact of pediatric nonadherence and enhance children’s health by reducing symptoms, impairment, health care utilization, and the costs of pediatric chronic illness treatment.